Role of estrogen receptors in pancreatic beta-cell survival and insulin secretion

Verification was completed by DMAPS/PSB PAGE(S) "2., M was not included in Original Application Package Date >2>D/ (* Initials Principal Investigator/Program Director (Last, First, Middle): MaUVaiS-JarvJS, Franck